CD4 T cell intrinsic signaling defects during viral exhaustion

Project Summary:
Chronic stimulation through the T cell receptor (TCR) drives T cells to progressively lose their ability to exert
their effector functions in a process termed exhaustion. T cell exhaustion occurs during both cancer and
persistent infections contributing to the failure of the adaptive immune response to control the tumor or
infection. CD8 T cell exhaustion was initially described during chronic lymphocytic choriomeningitis virus
(LCMV) infection. However, CD4 T cells control the delicate balance between the maintenance of effector CD8
T cell responses versus the development of CD8 T cell exhaustion during chronic infection. Despite their
critical role in maintaining the antiviral CD8 T cell response, much less is known about the specific signaling
defects and metabolic changes that occur within exhausted CD4 T cells. Gene expression studies examining
LCMV-specific CD4 T cells have indicated that hundreds of genes are differentially expressed between CD4 T
cells isolated during an acute versus chronic LCMV infection and that these genetic changes are different for
CD4 T cells versus CD8 T cells. Many of the differentially expressed genes in CD4 T cells are related to TCR
signaling and metabolic pathways, but how these alterations lead to specific defects in TCR signaling and
cellular metabolism has not been defined. Our long-term goal is to understand the mechanisms that mediate
CD4 T cell dysfunction during chronic viral infections and cancer progression. The objective of this application
is to determine the specific defects in CD4 T cell signaling and metabolic pathways that develop during chronic
LCMV infection. Our central hypothesis is that virus-specific CD4 T cells develop multiple defects in critical
signaling pathways downstream of the TCR and metabolic pathways, resulting in the impaired ability of the
CD4 T cell to mediate effector activity and proliferate during a chronic viral infection. Our hypothesis is based
our own preliminary data, in conjunction with published genetic studies, indicating that expression of multiple
signaling and metabolic proteins are reduced in virus-specific CD4 T cells following a persistent LCMV Clone
13 infection. The rationale for the proposed research is that, once the principal signaling and metabolic defects
affecting exhausted CD4 T cells are identified, new and innovative therapeutic approaches can be targeted to
restore CD4 T cell effector activity and enhance clearance of chronic viral infections and human cancers. We
will achieve the goals of this proposal by pursuing the following two specific aims: 1) Examine the effects of
viral exhaustion on early TCR signaling and function in CD4 T cells and 2) Investigate the impact of viral
exhaustion on metabolism in CD4 T cells. The completion of these aims will determine if T cell exhaustion after
infection with a chronic virus results in CD4 T cell intrinsic changes in the signaling capacity and metabolic
function that would impact effector functions. Our results will provide insight into the molecular mechanism of
CD4 T cell exhaustion and highlight potential avenues to modulate either signaling or metabolism to enhance
the function of exhausted CD4 T cells during either chronic viral infection or cancer immunotherapy.

Public health relevance
Project Narrative: Some viruses and human cancers have evolved mechanisms that inhibit critical aspects of the immune response that prevent effective elimination of the infection or malignant cell. The proposed research is relevant to public health because identifying the mechanisms that control immune system dysfunction during a chronic viral infection or cancer progression will increase understanding and treatment of the pathogenesis of chronic viral infections and human malignancies. Thus, the proposed research is relevant to the part of the NIH's mission that pertains to developing new therapeutic interventions aimed at reducing disease burden due to chronic viral infections and cancer.